CHARACTERIZATION OF DROSOPHILA MELANOGASTER--ETS AND ETS-LIKE GENES

Three Drosophila genes with cellular sequences related to the ets region of the chicken retrovirus, E26, have been isolated in this laboratory. The characterized portion of the most related gene, D-ets, shows over 90% identity with the last two exons of the chicken c-ets-1 gene at the predicted amino acid level. The region of D-ets (a genomic clone) 5' to this region has been shown to be present in a cDNA clone, and this sequence is divergent from the chicken c-ets-1 gene. D-ets is expressed as a 4.7 kb transcript throughout development. It is localized to chromosome 3R at position 58A/B. D-elg (Drosophila ets-like gene) is a related gene that has been localized to chromosomal position 97D on chromosome 3R. This gene is represented by a clone isolated from a pupae cDNA library. Its sequence shows 60% amino acid similarity with D-ets. D-elg is expressed as a maternal single transcript of 2.0 kb that is expressed throughout embryogenesis, as well as pupae and adult stages, but absent from larvae. A third gene, E13B, was identified by hybridization with v-ets, and a genomic clone has been partially sequenced. A cDNA clone that hybridized to E13B shows a long Poly A+ tail and is also being sequenced. The E13B gene is expressed as a 1.6 kb RNA species in pupae and adults only. It is located on chromosome 3L at position 66A. Control microinjection studies are beginning that will measure viability and fertility of injected embryos. A cDNA library has been constructed in order to find a full-length D-ets clone. Mapping of D-ets and D-elg by Sl and primer extension analyses are underway.